A Pilot for Enhancing Support for a Federated Framework of Biospecimens for Down Syndrome Research via the INCLUDE Data Hub

PROJECT SUMMARY
Under the proposed pilot, the respective biorepositories of the Children’s Hospital of Philadelphia and the Crnic
Institute Human Trisome Project Biobank will partner with the INCLUDE Data Hub to define and implement the
required workflows and tools to support biosample-based data/meta data integration. Such efforts will empower
portal users to engage cohort creation and biosample use frameworks via the INCLUDE Data Hub and their
downstream interactions with repositories as a combination of centralized and federated resources.

Public health relevance
PROJECT NARRATIVE The respective biorepositories of the Children’s Hospital of Philadelphia and the Crnic Institute Human Trisome Project Biobank will partner with the INCLUDE Data Hub to support the proposed development of a centralized biorepository data resource to coordinate a single biospecimen data repository or a network of repositories curating and distributing tissue specimens, cell lines, and associated derived analytes such as DNA, RNA, metabolites or proteins relevant to Down syndrome research. Coordinating the linkages between samples, clinical data, and derived biosample characterization data and/files such that a federated framework of queryable samples are available as an integrated resource to the investigator community remains a fundamental challenge. This project will address this unmet need in the field.